Research Core - Immunology & Informatics Core

Immunology and Informatics Core (IIC)
Abstract
The Immunology and Informatics Core (IIC) will provide critical support for Research Project Leaders (RPLs) by
allowing them to collect and analyze flow cytometry and omics data using advanced technologies and methods.
The core will provide access to a cutting-edge spectral flow cytometer, the first of this instrument class at
OUHSC, and train RPLs and their laboratories in how to prepare, run, and analyze samples using this instrument.
The IIC will provide informatics support and training opportunities for RPLs and members of their labs through
the “Omics for the Biomedical Researcher” workshop as well as by employing a fully trained Bioinformatics
Analyst. Specific areas of support provided to RPLs by the IIC include pre-project consultation, training in sample
preparation and wet-bench sample processing, immunophenotyping, and bioinformatics analysis and training,
post project data deposition, manuscript preparation, and assistance with future grant applications. As the core
develops, it is expected that the IIC will be used as a resource by other investigators at the institution that want
to incorporate immunology and informatics into their research programs.